PRD-containing Virulence Regulators of Pathogenic Streptococci

Bacterial pathogens must rapidly adapt to limiting nutrients during infection. The phosphoenolpyruvate
phosphotransferase system (PTS) is a conserved phosphorelay that couples sugar transport with
phosphorylation and serves as a monitor of carbohydrate flow in the bacterial cell. The Group A Streptococcus
(GAS) is a significant human-restricted pathogen causing a wide array of acute diseases in different host
tissues, resulting in over half a million deaths worldwide each year. Relevant to this renewal, GAS and other
pathogenic streptococci depend upon carbohydrate uptake systems for their ability to survive in the host. Mga
regulates virulence genes encoding immune evasion factors, adhesins, and sugar utilization operons, and we
have established over the previous grant period that Mga is directly phosphorylated by the PTS at conserved
histidines within PTS regulatory domains (PRD) that alter Mga-regulated gene expression and virulence in
GAS. Paralogs exist in GAS (RofA-like proteins, RALPs) as well as orthologs in other G+ pathogens such as S.
pneumoniae (MgaSpn) and B. anthracis (AtxA). Mga, with AtxA, form the paradigms for a family of PRD-
Containing Virulence Regulators (PCVRs) in G+ pathogens that that allow sugar availability to be
sensed by global virulence regulatory pathways and influence the disease process. Based on our substantial
published data, we posit that as GAS encounter changing or limiting sugar sources in the host, the PTS
phosphorylates Mga in PRD-1 to block dimerization and inhibit its activity, effectively shutting Mga off. Our
molecular dissection of the PTS in GAS has shown that glucose levels significantly alter PTS-mediated Mga
phosphorylation and the Mga regulon. However, many questions still remain. The goal of this renewal will be
to continue our pioneering studies on Mga as an archetype PCVR, while expanding our scope to other putative
PCVRs. In Aim 1, we will delineate how glucose uptake in GAS impacts Mga by defining the PTS and non-
PTS components for glucose uptake that influence Mga phosphorylation and activity using state-of-the-art
LC-MS/MS approaches to monitor phosphohistidines. In Aim 2, we will determine how non-glucose PTS
sugars signal through Mga in GAS using growth in PTS sugars with specific PTS EIIC mutants complemented
with Tn-seq to map Mga-specific genetic interactions in different PTS sugars. Aim 3 will focus on whether
paralogs and homologs of Mga are functional PCVRs by exploring whether the PTS directly phosphorylates
and influences the activity of paralogs in GAS (RofA, RivR), homologs in S. dysgalactiae (DmgB) and S.
pneumoniae (MgaSpn). Finally, Aim 4 will investigate the role of PTS regulation on Mga and RALP paralogs
in two host environments representing glucose levels known to affect Mga; bloodstream infection (high
glucose) using ex vivo and in vivo models, and mucosal colonization (low glucose) using a murine IL17-/-
NALT model. Advancing our understanding of PCVRs could lead to novel strategies to treat severe infections
caused by these important pathogens.

Public health relevance
Narrative Bacterial pathogens such as the Group A Streptococcus (GAS) must rapidly adapt to available nutrients in their human host and we have established in the previous period of this renewal application that the virulence regulator Mga is directly phosphorylated by the phosphotransferase system (PTS) within PTS regulatory domains (PRD) to alter Mga-regulated gene expression and thus virulence in GAS. Mga is the paradigm for a family of PRD-Containing Virulence Regulators (PCVRs) in Gram-positive bacterial pathogens that likely allow sugar availability to be sensed by global virulence regulatory pathways and directly influence the disease process. The goal of this renewal will be to continue our pioneering studies on Mga as an archetype PCVR, while expanding our focus to other putative PCVRs, to potentially discover novel strategies to treat severe infections caused by Gram-positive pathogens.